Quantitative Sciences Core

The Quantitative Sciences Core (QSC) of the Ponce Health Sciences University-Moffitt Cancer Center (PHSUMCC) Partnership provides resources and expertise for generating, managing, and analyzing big data. It is the
focal point for expertise in quantitative approaches to address the cancer characteristics of people in our
catchment area by enhancing our participation in “omics” studies and incorporating genetic variability analysis
in Partnership research approaches. By joining PHSU's expertise in genetic variability with the MCC
bioinformatics team, the QSC combines a unique set of skills required to address the molecular components of
cancer differences in genetically admixed populations. The QSC provides expertise in bioinformatics,
biostatistics, and informatics, and participates in every phase of the research life cycle. The QSC supports data
provisioning, study design, analysis plans, and power estimates to demonstrate the feasibility and improve rigor
and reproducibility in all Partnership research projects and grant submissions. In addition, the QSC contributes
to the dissemination of high-throughput molecular data by developing web-based visualization tools. As a central
resource for research projects, the QSC also facilitates collaboration, thereby leveraging the data gathered by
the Partnership investigators. The QSC analyzed the first catchment area genomic data generated in
collaboration with the Puerto Rico BioBank (PRBB)/Oncology Research Information Exchange Network (ORIEN)
Avatar and implemented a unique Partnership resource of cBioportal (GLOBAL), a web-based resource. The
QSC develops tools for visualizing and interpreting data, pipelines to estimate genetic variability, and has built
expertise in genomics bioinformatics at PHSU, including hiring, training, and the acquisition of computing and
storage infrastructure. The Specific Aims of the QSC will be: 1) Provide research project support for biostatistics
and bioinformatics from study design, endpoint definition, sample size estimation, power calculation, and data
analysis. Regular interactions between lead data scientists and project members will allow for the continuing
development of novel analytic tools to address emerging questions aligned with the Partnership’s needs. 2)
Provide data integration and management services for Partnership projects and cores. Projects needing
tissue/data collection systems will leverage the existing software infrastructure from PRBB Biospecimen
Management System (BMS). The QSC/PRBB Data Concierge provisions data and linkages from these systems.
Other supported services include the Partnership Bioportal, the Estimated Cell Line Ancestry (ECLA) tool, and
the Partnership Continuous Quality Improvement System for the Planning & Evaluation Core. 3) Provide
quantitative sciences expertise in support of the Partnership. The QSC aims to develop expertise in statistics at
PHSU; characterize publicly available molecular signatures in Partnership cohorts; develop analytics for PRBB
optimization of consent and participant communications; expand the omics experience for students (collaboration
with the Research Education Core), and enhance the use of genetic variability in quantitative studies.